Unraveling the role of satellite glial cells in sensory hypersensitivity in Fragile X syndrome

ABSTRACT
Fragile X syndrome (FXS) is the leading known genetic cause of autism spectrum disorders (ASD). Some
of the most prevalent symptoms of FXS and ASD are somatosensory deficits and hypersensitivity to sensory
stimuli. Increasing evidence suggests that sensory hypersensitivity leads to behavioral alterations such as
poor eye contact, anxiety, and impaired social interactions. Sensory hypersensitivity in FXS has thus far been
largely attributed to sensory processing deficits in brain circuits. Yet, despite two decades of intensive
studies, mechanisms of sensory deficits in FXS remain poorly understood and no targeted treatments are
available. Peripheral sensory neurons in dorsal root ganglia (DRG) receive direct sensory information from
the skin and convey it to the central nervous system. Activity of sensory neurons is modulated by satellite
glial cells (SGCs), which completely envelop each sensory neuron soma to form a morphological and
functional unit. SGC-neuron communication is bi-directional and provides feed-back control of neuronal
activity. Dysregulation of SCG-neuron communication is known to contribute to neuronal hyperexcitability in
many pain syndromes. Yet, whether SGC-neuron communication is disrupted in FXS and to what extent
SGCs contribute to sensory deficits in FXS remains poorly understood. In response to this challenge, we
began to explore potential deficits in SGC-neuron communication in Fmr1 KO mice, the FXS mouse model.
We found that sensory neurons exhibit pronounced hyperexcitability in Fmr1 KO mice. Our findings are in line
with recent studies in other models of ASD suggesting that core cognitive and sensory deficits may arise from
an earlier abnormality in sensory inputs that drive subsequent abnormal development of cortical circuits. In
addition to abnormalities in intrinsic neuronal mechanisms, we discovered that association of sensory
neurons with their enveloping SGCs is disrupted. Furthermore, transcriptional changes in both neurons and
SGCs indicate dysregulation of pathways involved in SGC-neuron communication. We will examine if and
how bi-directional signaling between neurons and SGCs is disrupted in Fmr1 KO. This will be achieved by
visualization and analysis of glutamate and ATP release in neuron-SGC communication. We will further
define the proteins secreted by SGC using mass spectrometry approaches and the changes in the SGC
secretome caused by FMRP loss. Finally, we will assess if targeting neuron-SGCs communication improves
neuronal excitability and, as a proof-of-principle, can normalize a subset of relevant behavioral deficits in the
FXS mouse model. We will also generate an SGC-specific Fmr1 KO to determine which defects in SGC-
neuron communication are specifically caused by loss of FMRP in SGCs. Our studies will provide foundation
to define the defects in SGC-neuron communication and how they contribute to sensory hypersensitivity in
FXS, with a potential to open new directions to ameliorate sensory deficits in FXS.

Public health relevance
PROJECT NARRATIVE Hypersensitivity to sensory stimuli is one of the hallmarks of Fragile X syndrome (FXS). Peripheral sensory neurons and their enveloping satellite glial cells in dorsal root ganglia form functional units that receive and process direct sensory information from the skin, but whether their communication is disrupted and contribute to sensory deficits in FXS remains poorly understood. We propose to define the defects in satellite glial cells - sensory neuron communication and determine how these defects contribute to sensory hypersensitivity in FXS, with a potential to open new directions to ameliorate sensory deficits in FXS.